Prompt Point-of-Care HIV Viral Load Monitoring

Rapid Diagnostic Assays for Self-Monitoring of Acute or Rebound HIV-Infection: This program aims to support early-stage diagnostic technologies as platforms for developing simple, low-cost, rapid diagnostic assays to enable individuals to directly detect HIV-1 during the earliest stages of initial infection or to monitor viral suppression in chronic treated infection times when antibody responses are not an accurate surrogate for viral load. This contract aims to address the need for a rapid diagnostic for at-home monitoring of HIV viral load using a portable, sample-to answer magnetofluidic platform.